mDOT Administrative Core

Principal Investigator: Kumar, Santosh
mDOT – Administration Core
Abstract:
The mHealth Center for Discovery, Optimization & Translation of Temporally-Precise Interventions (the mDOT
Center) will enable a new paradigm of temporally-precise medicine to maintain health and manage the growing
burden of chronic diseases. The mDOT Center will develop and disseminate the methods, tools, and
infrastructure necessary for researchers to pursue the discovery, optimization and translation of temporally-
precise mHealth interventions. Such interventions, when dynamically personalized to the moment-to-moment
biopsychosocial-environmental context of each individual, will precipitate a much-needed transformation in
healthcare by enabling patients to initiate and sustain the healthy lifestyle choices necessary for directly
managing, treating, and in some cases even preventing the development of medical conditions. Organized
around three Technology Research & Development (TR&D) projects, mDOT represents a unique national
resource that will develop multiple technological innovations and support their translation into research and
practice by the mHealth community in the form of easily deployable wearables, apps for wearables and
smartphones, and a companion mHealth cloud system, all open-source.
Given that the inherently transdisciplinary, team-based nature of mHealth research requires scientists to cross
disciplinary and institutional boundaries, administration and operation of a functional resource center in mHealth
technologies requires a collaborative culture, with a team-science approach, that is geographically dispersed yet
functional in a virtual setting. mDOT will utilize its established and highly successful infrastructure, adaptive
procedural acumen, widely visible dissemination platforms, and deeply-experienced team to develop
administrative and operational policies and procedures relevant to the running of a national resource center. The
Administration Core will look to not only enhance the research of the collaborative projects (CPs) and service
projects (SPs), but also to streamline communication and involvement with new research groups with little or no
technological expertise. To achieve its goals, mDOT will pursue the following activities. First, mDOT will leverage
an established organizing structure and managerial practice to facilitate coordination, communication, and
collaboration among the team, CPs, SPs, and greater research community. Secondly, mDOT will establish
operational procedures that allows for successful work with the CPs and SPs – this includes mechanisms to
receive, vet, and approve the use of resources and devising criteria to prioritize the selection of other qualified
CP/SP candidates. Third, mDOT will recruit eminent scholars and nationally recognized thought leaders to serve
on a diverse external advisory committee (EAC) tasked with providing feedback and guidance on the mDOT
research agenda. Fourth, mDOT will secure and leverage institutional support that accommodates and sets up
the Center for success in achieving the research goals put forth by the investigating team. Finally, the
Administration Core will develop measurable metrics to monitor, assess, and evaluate the quality and utility of
mDOT technologies while taking a customer service approach that is adaptive to feedback and responsive to
the mHealth research community at large.
1

Public health relevance
Principal Investigator: Kumar, Santosh mDOT – Administration Core Public Health Relevance: mDOT will equip the transdisciplinary mHealth research community with mDOT technologies and methods to discover, optimize, and deploy temporally-precise mHealth interventions. Adoption of mDOT technologies will give rise to a new research paradigm and precipitate a much-needed transformation in healthcare by enabling patients to initiate and sustain the healthy lifestyle choices necessary to prevent and/or successfully manage the growing burden of multiple chronic conditions. 2